DIFFERENCES IN MARIJUANA SELF ADMINISTRATION

This study proposes to examine potential differences in the self-administration and consequent effects of smoked marijuana between individuals with and without family histories of alcoholism, and between individuals reporting light vs heavy use of marijuana.